Project 2: Phase 1 and Phase 2a ZB-06 Clinical Studies

PROJECT 2 - ABSTRACT
Our team developed a non-hormonal, on-demand, female-controlled, non-surfactant, contraceptive vaginal film
that releases an innovative human contraceptive antibody (HCA). The HCA film could fill an important gap in
the current contraceptive method mix for women worldwide. Project 2 will conduct two United States Food and
Drug Administration (US FDA) required clinical studies, which will build upon progress made in our ongoing
award (NICHD P50 HD096957). Under an exploratory investigational new drug protocol, Eastern Virginia
Medical School (EVMS) (PI Thurman) is currently conducting the first-in-human, post coital testing (PCT),
pharmacokinetic (PK) and safety study (ClinicalTrials.gov #NCT04731818) of a single, 20 mg dose of the HCA
film, inserted 30 minutes prior to unprotected intercourse at peak ovulation. Current data support that the 20 mg
film is safe and acceptable for both the woman and her male sexual partner. All product use PCT data thus far
support contraceptive efficacy, showing less than 5 progressively motile sperm (PMS) per high powered field
(hpf) in ovulatory cervical mucus (mean = 0.05 PMS/hpf, n= 7 women). Specific Aim 1: The operations planning,
technical content generation, site training, and local regulatory filings to prepare for the next clinical trials will
begin immediately. Specific Aim 2: We will conduct a Phase I, Placebo-Controlled, Double-Blinded, Randomized,
Interventional, Safety and PK study of Single and Multiple Dosings of the HCA 20 mg film at EVMS. This study
will include FDA required safety assessments and also innovative assays which quantify sub-clinical changes
relevant to topical vaginal product safety. Specific Aim 3: We will conduct a Phase 2a, multi-center [EVMS and
University of Texas at San Antonio (UT Health)], dose finding (5 mg vs. 10 mg vs. 20 mg), PK study of the HCA
film. We will use an adaptive study design, starting with the lowest dose. The PCT endpoint will be used as an
in vivo surrogate of contraceptive efficacy. We will examine a range of pre-coital dosing time frames (15 min –
4 hours) to assure that this product fits in to the lifestyles of future end users. Project 2 will be closely integrated
with Project 1 and its lead institution, ZabBio, who will provide the active and placebo films, and monitoring and
auditing of the clinical studies. Likewise, Project 2 will interface closely with the Administrative Core at Boston
University, which will provide data management and statistical support. Clinical samples from Project 2 studies
will be analyzed by Project 3; the Boston University lab will use innovative assays to quantify the effect of 14-
day dosing on sub-clinical mucosal safety signals (epithelial barrier quality, sub-clinical pro-inflammatory
proteins) and to describe any changes in the vaginal microbiome with film use. Samples from both clinical
studies will be analyzed by Project 3 to confirm that HCA film use does not elicit the development of endogenous
anti-sperm immunity locally or systemically. The study will deliver important data from two FDA required studies,
which will position this product for Phase 3 efficacy testing and commercialization.